Machine learning approaches to personalized cigarette smoking risk prediction in adults trying to quit

PROJECT SUMMARY
Cigarette smoking is the leading preventable cause of death and claims more than 480,000 lives in the US
each year. Roughly 20 million adults in the US want to quit smoking tobacco. At least 7 million people access
digital resources (e.g., Smokefree.gov) on this topic each year. Although evidence supports many tobacco
treatment interventions, absolute quit rates remain low and relapse or continued smoking is the most common
outcome of most quit attempts, even with treatment. Personalized treatment is a promising strategy that may
enhance the effectiveness of smoking therapies and deliver the right support for a particular person at a
particular time in the quitting process. Sophisticated, high-dimensional data analytic approaches are needed to
account for the complexity and intersectionality of influences on smoking lapses and relapses during quit
attempts, and to develop robust and effective personalized risk predictions and interventions. Identifying the
dynamic patterns and key features of individuals, events, and contexts that predict smoking during quit
attempts could inform treatment delivery in multiple ways (e.g., clinical decision support tools for treatment
teams, smartphone quitting apps). This K23 career development proposal aims to enhance Dr. Kaye’s capacity
to pursue the important public health goal of improving smoking cessation treatment personalization by
teaching him how to apply powerful new machine learning methods to this effort. Specifically, he will apply
machine learning methods to rich existing datasets from diverse samples of adults trying to quit smoking. Trials
combine extensive assessment of individual differences (e.g., demographics, smoking history, comorbidities)
and ecological momentary assessment of time-varying risk (e.g., craving, stress, anhedonia) and protective
factors (e.g., quitting self-efficacy, medication adherence). The use of data from multiple clinical trials offering
varying treatments (e.g., counseling, medications, smartphone apps) creates opportunities to assess the
robustness of smoking risk prediction across treatment contexts. This project will conduct secondary data
analysis of 4 smoking cessation clinical trials (total N=3023), using machine learning methods to develop, train,
and validate: 1) a long term smoking relapse prediction model based on baseline (pre-treatment) data, and, 2)
a smoking lapse risk prediction model based on baseline data and dynamic time-varying risk signals. Dr. Kaye
will receive training and mentoring in tobacco treatment (Training Goal 1: Drs. McCarthy, Baker), feature
engineering to generate predictors (Goal 2: Drs. McCarthy, Curtin, Bolt, Loh), multiple machine learning
methods (Goal 3: Drs. Curtin, Bolt, Loh), and digital just-in-time adaptive interventions for substance use (Goal
4: Drs. Businelle, Curtin). The K23 will generate new knowledge about how to predict near- and long-term
abstinence outcomes and inform hypotheses about when, how, and for whom to deliver personalized
interventions to people trying to quit smoking. The K23 will also launch Dr. Kaye’s program of research to
develop open-source, publicly-available risk prediction models that can be incorporated in future treatments.

Public health relevance
PROJECT NARRATIVE Personalized treatment is a promising strategy that may enhance the effectiveness of smoking therapies and deliver the right support for a particular person at a particular time in the quitting process. Machine learning approaches afford the opportunity to develop sophisticated models that predict long-term smoking cessation abstinence outcomes and daily smoking lapse risk. The machine learning approaches developed in this project will inform hypotheses about when, how, and for whom to deliver personalized treatment planning and real- time interventions to people trying to quit smoking in future digital and non-digital intervention approaches.